A Randomized Hybrid Type I effectiveness-implementation study of an Ehealth delivery Alternative for Cancer genetic testing for Hereditary cancer predisposition (eREACH)

Germline cancer genetic testing has become a standard evidence-based practice, with established risk reduction
and cancer screening guidelines for genetic carriers. Yet, access to genetic specialists is limited in many areas
in the US, and <20% of eligible patients with a personal or family history of breast or ovarian cancer complete
genetic testing. Thus, there is an urgent need to consider alternative delivery models to increase access and
uptake of genetic testing, while maintaining adequate patient cognitive, affective and behavioral outcomes. Our
research has shown that providing remote services increases uptake of genetic testing in community practices
increases uptake of genetic testing. Preliminary data from our ongoing NIH-funded RESPECT study has
revealed high interest in a web-based eHealth alternative to traditional pre-test counseling and no significant no
differences in pre- and post-disclosure outcomes when the web-based eHealth intervention is utilized as
compared to participants who received traditional pre-test genetic counselor. To address the clinically significant
need for alternative delivery models to increase access and uptake of cancer genetic testing, while maintaining
adequate patient cognitive, affective and behavioral outcomes, we propose to recruit a nationally diverse “real-
world” sample of 1000 patients who have access barriers to genetic testing and to conduct a Hybrid Type 1
effectiveness-implementation study to evaluate web-based eHealth delivery alternatives for genetic education
and testing. We hypothesize that our theoretically and stakeholder informed eHealth delivery alternatives can
provide equal or better uptake of testing and outcomes of genetic testing as compared to the traditional model
of pre- and post-test counseling with a genetic counselor. We will partner with several cancer advocacy groups
(ASCO, breastcancer.org, Cancer Support Community, Pennsylvania Prostate Cancer Coalition) to recruit
patients to this randomized non-inferiority study using a modified 2x2 design (Aims 1-2). In Arm 1, traditional
pre-test (visit 1) and post-test (visit 2: disclosure) counseling will be provided remotely through the national Penn
Telegenetics Program and compared to delivery arms where patients can complete pre-test and/or disclosure of
results through a self-directed web-based eHealth intervention, either in place of, or as an adjunct to traditional
genetic counseling. Concurrently, we will conduct a CFIR (Consolidated Framework for Implementation
Research)-informed process evaluation to understand moderators of intervention usage and patient outcomes
and facilitators and barriers to future implementation and sustainability of this novel eHealth alternative delivery
model for genetic services both within and beyond cancer care (Aim 3). We hypothesize that a rigorously
developed theoretically and stake-holder informed eHealth delivery alternative provided through a centralized
Telegenetics Program has the potential to provide equal or improved patient outcomes, while reducing genetic
provider time and providing access to services in community practices where access to genetic services has
been limited, providing opportunities to realize the promise of precision medicine in oncology.

Public health relevance
In the eREACH study we will evaluate a theoretically and stake-holder informed eHealth delivery alternative to traditional genetic counseling, recruiting a nationally representative population of patients who are candidates for genetic testing for cancer susceptibility. We expect this research to significantly inform how best to deliver and communicate results of genetic testing in a way that provides access for all patients across the US, while maintaining adequate understanding and clinical use of genetic test results.